KSHV Replication and Trained Immunity

This application is in response to the Notice of Special Interest (NOT-DE-25-038): Basic and Translational Oral
Health Research Related with HIV/AIDS. As stated in the NOSI, oral malignancies in people living with HIV
(PLWH) are associated with enhanced local and systemic inflammatory states and closely linked to other viruses,
such as Kaposi’s sarcoma-associated herpesvirus (KSHV). It has been known that a significant amount of KSHV
virion is identified in saliva and KSHV-linked KS tumors in the oral cavity.
Our application aims to understand the association between inflammatory tissue environment and KSHV
replication. Our hypothesis is that cellular inflammatory signaling support the activation of a KSHV gene
enhancer, which helps to maintain reactivatable latent chromatin. We will focus on viral IL-6 (vIL-6) functions to
dissect the contribution of inflammatory signaling in KSHV replication and reprogramming of infected cells.
Because the oral cavity is constantly stimulated with inflammatory signaling by oral bacteria, we hypothesize that
such tissue environment allows KSHV to maintain epigenetically active latent chromatin.
Trained immunity is a recently recognized feature of immune regulation, in which immune cells respond
more quickly and robustly to subsequent exposure to similar triggers via transcription memories. Accumulating
evidence suggested the broad benefit of trained immunity for normal host defense when cytokine expression is
tightly controlled. However, studies also linked the transcriptional memory with chronic inflammatory disease
when cellular responses continue to be overly reactive. In cells infected with the KSHV, an inflammatory viral
cytokine is strongly expressed from viral gene independent of the tightly controlled host immune signaling
networks. A critical question also pertains to why KSHV evolutionarily maintains multiple cytokine homologues
that activate host inflammatory responses. KSHV infection is indeed associated with inflammatory diseases,
including Kaposi's sarcoma and KSHV inflammatory cytokine syndrome (KICS). KSHV genome is also frequently
maintained (detected) in inflammatory tissues such as the oral cavity and KS tumor.
Here, we propose to study a hypothesis that KSHV utilizes a host cell trained immunity function by
inducing cellular inflammatory signaling for its replication with vIL-6. We will study how KSHV vIL-6 re-programs
viral and host gene expression by activating respective genomic enhancer domains to form transcription
memories. We will also reveal whether the inflammatory tissue microenvironment is associated with maintaining
active (re-activatable) latent chromatin. Completing this study should increase our understanding of the vIL-6
function in viral replication and association with KSHV pathogenesis.

Public health relevance
PROJECT NARRATIVE Transcriptional memory is a biological phenomenon first described in yeast genetics and now widely seen in other organisms. Studies on disease-associated transcriptional memory, which is often associated with over- reactions via trained immunity, will provide insight into chronic disease development. We will reveal how prolonged cytokine exposure caused by virally encoded interleukin 6 (vIL-6) reprograms transcription and affects cell behavior and viral replication.